Stress and Opioid Misuse Risk: The Role of Endogenous Opioid and Endocannabinoid Mechanisms

Abstract
Indiscriminate prescribing of opioids for chronic pain management has contributed to the current opioid
crisis. While opioids work well at stable doses for some patients, others experience poor pain relief with
significant risks of developing iatrogenic opioid use disorder (OUD). Similar risks may occur in the context of
extended postoperative pain management using opioids following major surgery. Ability to predict this
risk/benefit balance for individual patients is limited by inadequate understanding of mechanisms influencing
opioid responses and risks. To address this gap, our prior funded work has systematically evaluated
mechanisms contributing to differential opioid responses. We have shown that: 1) chronic pain patients at
increased risk of opioid misuse experience greater analgesia and subjective reinforcing effects of opioid
analgesics (e.g., drug liking, desire to take the drug again), 2) low endogenous opioid (EO) function predicts
greater analgesic responses to opioid analgesics (replicated across two studies), and 3) that low EO function
and endocannabinoid (EC) levels together predict greater subjective opioid reinforcing effects. Our data are
consistent with a reinforcement model in which differential opioid responding related to low EO and EC function
may enhance risk of OUD. Stress is a known predictor of risk for OUD, but mechanisms are not well
understood. EO and EC activity are however both known to inhibit stress responses. This project integrates
diverse literatures and will test in 120 chronic low back pain patients a novel mechanistic model in which
elevated stress, via links to low EO and EC activity, contributes to patterns of differential opioid responding that
will enhance OUD risk via elevated opioid reinforcing properties. Primary aims are: 1) to determine whether
stress-related measures are associated with analgesic and misuse-relevant subjective responses to placebo-
controlled oxycodone administration, and 2) evaluate associations between stress-related measures and both
EO function and EC levels, and test whether EO and EC mechanisms mediate associations between stress-
related measures and oxycodone responses. This project will assess stress at multiple levels (subjective,
cardiovascular reactivity to two controlled stressors, and pain-relevant heart rate variability [HRV] stress
markers) with quantitative assessment of EC levels, and assessment of EO function and opioid agonist
subjective and analgesic responses based on randomized, placebo-controlled crossover administration of
naloxone (for EO) and oxycodone (opioid responses). Laboratory stress measures will be validated using
EMA electronic diary assessment of stress. Results will provide unique mechanistic knowledge of
mechanisms contributing to known associations between stress and OUD risk, in line with the goals of PAS-
18-624, and highlight a novel and clinically-pragmatic HRV measure that might predict risk-enhancing
differential opioid responses before initiating opioid therapy.

Public health relevance
Project Narrative Elevated stress is known to enhance risk for opioid use disorder (OUD), a significant problem given the broad use of opioid analgesics in both acute and chronic pain management. This project will test an innovative model in which low endogenous opioid (EO) and endocannabinoid (EC) activity associated with elevated stress both contribute to increased OUD risk via their association with heightened reinforcing effects of opioids (e.g., drug liking). Results will provide important new mechanistic understanding of how stress increases OUD risk, and may identify a novel and clinically-pragmatic marker of risk-enhancing differential opioid responding.